Developmental Core

Developmental Core
The PCHPI seeks to foster and strengthen the collaborative spirit between HIV-1 investigators and structural
biologists, to accelerate their careers and instill confidence in cross-disciplinary approaches, as described in our
Overall Aim 1. To empower the next generation of HIV-1 and structural biology scientists and to usher them
toward research independence, we will establish a Developmental Core, which will design and implement
programs to accelerate the research and independent career development of early-stage faculty and pre- and
postdoctoral investigators who are engaged in HIV-related studies. These programs will include a Collaborative
Development Award Program to aid talented early-stage HIV-1 virology and structural biology faculty reach their
research goals, a mentored scientist program to foster the career of early-stage faculty, and a Researcher
Embedding Program to enable new skill acquisition and networking opportunities as well as open new thought
spaces for broadening knowledge about approaches in other disciplines, among others. Together, the programs
established through the Developmental Core will provide unique opportunities for long-lasting mentor/mentee
relationships and will extend the reach of the PCHPI to the broader HIV-1 and structural biology research
communities.